Developmental control of gene silencing

Project Summary
Cells sharing a common genome transcribe a subset of their available genes to perform different functions.
Polycomb-group (PcG) proteins contribute to cell specialization by binding and chemically modifying chromatin
around lowly-transcribed genes to further reduce (“silence”) their expression. Although many PcG proteins have
been identified, mystery surrounds the most interesting aspects of their function. The utility of silencing derives
from its selective imposition. However, unknown mechanisms determine when silencing begins or ends during
normal development. Furthermore, how PcG proteins epigenetically associate with different target genes in
different cells is poorly understood. It is important to resolve these questions because silencing mistakes disrupt
development and contribute to human cancers. The proposed research program uses a new model system,
Drosophila nurse cell differentiation, and new genetic and genomic engineering tools to study how silencing
initiation, maintenance, and reversal are developmentally regulated. The proposed model system overcomes
technical limitations of studying silencing initiation in early embryos and embryonic cell cultures. A new proposed
tool, termed UAS-gene swap, allows genetic substitution of PcG proteins with mutant versions in thousands of
cells, and is compatible with sensitive molecular approaches like ChIPseq. The first proposed research direction
will use UAS-gene swap to identify the interactions between PcG proteins and transcription factors that are
important for establishing or preventing silencing at each potential Polycomb target gene. A second research
direction will explore how a single PcG protein, Scm, is post-translationally regulated to time silencing initiation
in differentiating nurse cells and other developmental contexts. Finally, a third research direction will use a highly-
efficient genome engineering approach to explore how some Polycomb target genes are stably silenced while
others are not. These diverse directions will significantly advance our understanding of how development
regulates Polycomb silencing. They will also generate new tools to study gene expression control in developing
organisms that will be valuable to the broader research community. Lastly, this research program may reveal
potentially conserved mechanisms that regulate early embryonic development and prevent human cancers.

Public health relevance
Project Narrative Each of our cells inactivates many of its available genes to perform a unique function. Failure to properly inactivate genes underlies developmental disorders and devastating pediatric brain and blood cancers. This project investigates how cells inactivate the correct genes at the correct time during development to understand how defective gene inactivation can cause disease.